Integrated system for PET radiotracer synthesis

PROJECT SUMMARY/ABSTRACT
The goal of this proposal is to install an integrated radiosynthesis system for the production of non-commercially
available PET radiotracers for preclinical imaging applications at the UC Davis Center for Molecular and Genomic
Imaging (CMGI). We propose to incorporate a commercial radiosynthesis unit dedicated to the production of
PET radiotracers complete with shielding enclosures allowing the safe and efficient production of the
radiotracers. The integrated system will allow for the automated production of PET radiotracers radiolabeled with
the positron emitter fluorine-18. It includes all necessary components to support radiotracer production and will
allow us to synthesize both established and novel PET radiotracers. As the NIH roadmap calls for an emphasis
on translational research and has identified molecular imaging as a priority, UC Davis is proposing to strengthen
functional and molecular imaging in animal models for future translation to humans by utilizing the system. The
system will be installed at the CMGI, which is a campus-designated and supported core facility providing
infrastructure and expertise to conduct in vivo imaging studies in animal models, from rodents to non-human
primates and companion animals. CMGI is the only location on our campus that oversees a cyclotron and
radiochemistry facilities dedicated to preclinical imaging research. Institutional support provided to the CMGI
ensures the successful operation and maintenance of the system for its lifetime. The system will support at least
10 major and minor users who are conducting NIH-funded research in diverse areas such as gene therapy,
neurology, oncology, toxicology, metabolic disorders, nanotechnology and biomedical engineering.

Public health relevance
PROJECT NARRATIVE A radiosynthesis system for the production of fluorine-18 PET radiotracers will significantly advance the scientific investigations of users of the UC Davis Center for Molecular and Genomic Imaging who utilize NIH funding. Diverse areas such as gene therapy, neurology, oncology, toxicology, metabolic disorders, nanotechnology and biomedical engineering stand to directly benefit from the unique capabilities of the system and the plethora of invaluable data it will produce regarding disease initiation, pathogenesis and response to therapy.